The Role of Donor-Derived Eosinophils on Lung Allograft Ischemia Reperfusion Injury

PROJECT SUMMARY/ ABSTRACT
Despite advances in organ recovery a large number of lung transplant recipients suffer from primary graft
dysfunction associated with ischemia-reperfusion injury (IRI) of the donor graft. Such injury can result in an
increased risk of both acute and chronic rejection and substantially decrease survival. Translational research
focusing on cellular mechanism/s of injury can set the foundation for therapeutic intervention. In this proposal
we expand on a novel finding that donor-derived eosinophils contribute to lung allograft damage during organ
storage and after reperfusion. Depletion of eosinophils from the donor lung prior to engraftment decreases IRI
and improves pulmonary function. This finding is in direct contrast to discoveries made during the previous
cycle of this grant, where we uncovered that recipient-derived eosinophils limit both cellular and humoral
rejection. Thus, our data indicate that eosinophils can be beneficial or deleterious to graft survival based on
the context and local environment. The aims outlined in this grant test our central hypothesis that organ
storage and reperfusion lead to activation of donor-derived eosinophils that results in graft damage. Such
damage may be mitigated by blocking eosinophils and eosinophil activation. To explore this in greater detail in
Aim #1 we will focus on stress ligands and components of organ preservation solution that activate
eosinophils. In Aim #2 we will evaluate mechanism/s of how eosinophils can mediate organ damage and in
Aim #3 we will explore clinically relevant methodology to either prevent eosinophil activation or mediate their
depletion during the process of organ preservation. Our data will both provide novel insight into cellular
immune responses contributing to ischemia-reperfusion injury and set the stage for translational protocols to
improve outcomes.

Public health relevance
The role of eosinophils in lung transplantation is only now becoming understood. We have recently identified that eosinophils residing in the donor lung can mediate organ damage during both static storage and after reperfusion. Here we explore the mechanism/s of donor-derived eosinophil activation and cytotoxicity in the lung graft and explore translational protocols to ameliorate activation of such eosinophils with the hope of improving graft function and long-term survival.